Role of brown adipose tissue (BAT) in energy balance

Summary:
Thermal biology is different between small and large mammals. At typical ambient environmental temperature (eg., 22 C), over one third of energy expenditure in mice is devoted to maintaining core body temperature, largely by brown adipose tissue (BAT). To conserve energy, mice can enter a regulated hypothermia, while humans do not. Since humans expend little or no energy specifically to keep warm, mice studied at 30 C (near thermoneutrality) may be a better model for human energy homeostasis. In mice, dinitrophenol, a protonophore, and CL316243, a beta3-adrenergic agonist, both increased metabolic rate at thermoneutrality but only CL316243 increased it at 22 C. Mice housed at 30 C also may become more obese than mice at 22 C. The effect of environmental temperature must be understood to ensure applicability of mouse experiments to human obesity.

Progress in FY2024-2025 includes the following:
We are continuing to study subpopulations of preoptic area neurons expressing BRS3 (POA-BRS3) neurons whose activation increased body temperature; inversely, acute inhibition of these neurons reduced body temperature. We have also begun to explore the role of histamine-1 receptors, encoded by the Hrh1 gene.

Ongoing work is comparing thermal biology at 22C vs 30C in mice compared to rats.